Tissue regulation of T cell function - Reagents Core

PROJECT SUMMARY / ABSTRACT – REAGENT CORE
Recruitment and localization of leukocytes to sites of infection in inflamed tissue is a dynamic and regulated
process that depends on cross talk between different cell populations, responses to specific environmental
cues, and the expression of appropriate effector molecules. The overall goal of this program project is to
define key molecular and cellular processes that regulate effective T cell immune responses in peripheral
tissue during the initial innate inflammatory response, during effector T cell activation, and during the
generation and persistence of tissue-restricted memory. In concordance with this overall goal, the goal of this
reagent core is to develop reagents that will enable us to both monitor and manipulate key molecules in a
spatially and temporally regulated fashion in specific cell types. The reagents developed in the core will enable
all of the projects to probe the functional significance of specific intracellular and membrane-associated events
that change as cells interact with other cells and within specific microenvironments in inflamed tissue. The
Reagent Core has three aims:
1. To generate retroviruses expressing genetic reporters to image functional events and to manipulate
expression of key proteins in T cells. We will generate retroviruses that can be used to localize and
manipulate structural proteins that regulate T cell migration and ECM interactions (integrins and cytoskeletal
proteins), to monitor intracellular signaling events, and to modify gene expression.
2. To generate and maintain breeding stocks of genetically modified mouse strains that tag specific
leukocyte populations with different fluorescent tags. To fully understand how cellular cross talk can
influence an immune response, it is necessary to define the cell populations that are present within the
inflamed tissue. The goal of this aim will be to maintain a breeding colony of genetically modified mouse lines
that express tissue specific fluorescent reporters to identify and distinguish T cells and different myeloid cell
populations in inflamed tissue. This repository will enable investigators to “mix and match” fluorescently tagged
cells and recipient mice as they plan IV-MPM experiments
3. To create new mouse models to allow for identification and/or manipulation of key leukocyte
subpopulations. In this aim we propose to generate several new animal models that are not currently
available commercially or collaboratively. These will include mice that express leukocyte subpopulation-
specific fluorescent tags, as described in Aim 2 and floxed alleles for integrins (Alpha 1 and Alpha E) that
regulate the positioning and function of CD8 TRM cells.